Evaluation and Implementation of Malnutrition Screening tools in dental settings

Project Summary/Abstract
Tooth loss is still a public health concern, and it affects daily oral functions thereby impacting general health.
Even though tooth loss can be rehabilitated through dentures, chewing efficiency declines compared to natural
dentition, affecting one’s nutritional intake. Individuals who have lost all their teeth or partially dentate with and
without prostheses are known to be at risk for malnutrition. As a result, it is essential to monitor their nutritional
profile among adults experiencing edentulousness and receiving prosthodontic treatments. However, this is not
a common procedure during dental visits. Although, many malnutrition screening (MS) tools exist in general
health settings they are not used in dental practices because of lack of evidence for the tools’ performance, on
the usability, and lack of understanding of patient outcomes among individuals with dentures. The long-term
goal for our proposed research study is to facilitate a patient-centered healthcare system by translating the
best scientific evidence into clinical practice through clinical decision support systems (CDSS), especially those
that emphasize continuity of care between dental and other healthcare providers. The objective of this career
development award is to evaluate the accuracy and performance of the three malnutrition screening tools,
Nutrition Screening Initiative (NSI), Mini Nutritional Assessment-Short Form (MNA-SF), and Malnutrition
Screening Tool (MST), and use them to screen and refer to a clinical registered dietitian, and to evaluate the
feasibility of the tools’ implementation in dental practices. The rationale for this proposed work is to identify and
refer denture-wearing patients at risk for malnutrition, and to reduce the risk for experiencing adverse effects of
malnutrition which would compromise their quality of life. To accomplish the goal, I propose the following three
specific aims: 1) Evaluate the usability of three MS tools with end users (denture wearers) and assess the
tools’ accuracy in identifying malnutrition risk by comparing their results to a gold standard: a registered
dietitian’s nutritional assessment. 2) Determine dental clinicians’ opinions of the three malnutrition screening
tools and their perceived facilitators and barriers to implementing these tools in dental practices. Focus groups
with DCs will collect information on their perspectives, opinions, knowledge, attitudes, and recommendations
on using the MS tool for clinical decision-making by using the consolidated framework for implementation
research (CFIR). 3) Evaluate the feasibility and effectiveness of implementing in dental practices the three
malnutrition screening tools for screening and referring patients who receive/wear dentures. Iterative usability
testing with denture wearers, clinicians, and contextual inquiry (CI) observations in dental practices will be
used to understand the ease in use of the tool by the end user within the clinical workflow. The outcome of this
research is to provide scientific evidence on the effectiveness of using malnutrition risk screening with denture
wearers in dental practices. The proposed work will inform on the design and implementation of MS tools.

Public health relevance
Project Narrative The present proposal aims to establish an approach to evaluate the feasibility of implementing malnutrition screening (MS) tools in dental practices to screen individuals wearing dentures for risk of malnutrition and refer them to a registered dietitian. Screening for malnutrition is seldom practiced in a dental setting, creating a greater need to determine the effectiveness of MS tools among denture wearers in a dental setting. Results from this study will facilitate a patient-centered healthcare system by translating evidence-based findings into clinical practice through clinical decision support systems and converging oral and general healthcare.